BRADYKININ 2 RECEPTOR EXPRESSION IN HYPERTENSION

Compare the cutaneous response to bradykinin between normotensives and hypertensives, African American and Caucasian, and between African Americans wit without a istory of ACEI-associated angioedema and compare skin fibroblast BK-2 receptor binding characteristics and receptor gene expression of all groups. Recruiting subjects is the current focus for this study.